Communication Support

The Division of Cancer Prevention, NCI is the primary point for research on cancer prevention, early detection, community oncology, and supportive care within NCI. The division maintains a website highlighting information about its projects and programs to inform extramural researchers, the NCI/NIH community, and the general public about this critical research. We are a major portal through which the public finds NCI’s prevention, early detection, and supportive/palliative care research information. Contractor resources are being sought to assist in the production of new website design and content management system for the main DCP website, content additions to the CCOP website and with communications planning and support for an entirely new NCI program, the NCI Community Oncology Program in addition to other communications support projects, such as webinars.

Public health relevance
Public Health Relevance: DCP websites a major portals through which the public finds NCI’s prevention, early detection, and supportive/palliative care research information.